Mechanisms of Protective Local Immunity in Human Female Reproductive Tract

DESCRIPTION (provided by applicant): The prevalence of sexually transmitted diseases (STDs) has increased globally with severe medical and psychological consequences. Despite major efforts, vaccine development aiming to either prevent or treat sexually transmitted infections (STIs), such as HIV and herpes simplex virus type 2 (HSV-2), has been largely unsuccessful. The mucosal surface of the vagina and ectocervix serves as both the point of entry as well as a barrier against sexually transmitted pathogens. Tissue-localized memory T cells provide a first line of defense in the skin and mucosa, by targeting infected cells directly and also by recruiting memory T cells from the circulation. We have shown that CD8 T cells not only infiltrate to the site of infection, but also persist in genital skin and mucosa for prolonged time periods after viral clearance. Our recently published work (Nature, 2013) indicates that CD8 T cells resident in human genital skin post healing of HSV-2 genital lesions express the CD8?? homodimer as a co-receptor instead of the heterodimeric CD8?ß, which dominates blood circulating CD8 T cells. Surface expression of the CD8?? homodimer is also characteristic of intraepithelial lymphocytes (IEL) resident in the gut epithelium and mucosal associated invariant T cells (MAIT). CD8?? has been proposed to preserve high-affinity effector T cells for long-lived mucosal memory. Whether CD8?? expression is a general mechanism for tissue resident memory in the human periphery is currently unclear. Here, we propose to investigate the immunological relevance of CD8?? T cells in the human female reproductive tract (FRT) using biopsies of vulva, vagina and ectocervical tissue, as well as the residency status of CD4 T cells. The overall goal of this proposal is to define the resident statuses of memory CD8 and CD4 T cells in FRT tissue compartments and to determine the mechanisms underlining their local retention, function and self- renewal capability. Using a combined approach of cell-type-specific laser capture microdissection (LCM), transcriptional profiling, high-throughput sequencing technology and multicolor confocal microscopy, we aim to 1) define the spatial dynamics of CD4, CD8?? and CD8?ß T cells in the vulva, vagina and cervix; 2) determine the mechanism of tissue retention and function of memory T cells resident in human FRT; and 3) define microenvironmental cues promoting local proliferation of resident T cells. We believe a thorough investigation of cellular immunity in human FRT will broaden our knowledge of tissue resident immunity at the anatomical site of STI acquisition and transmission. These studies can then directly inform design of future vaccines and immunotherapeutic approaches that elicit tissue resident immune response with the hope of effectively protecting against STIs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the immune responses in the mucosal surface of human female reproductive tract is an important component for future vaccine design and novel interventions to reduce sexual transmitted disease impact on public health. This proposal aims to define the local dynamics of tissue-based T cell memory and their interplay with the microenvironment.